Influence of sleep on hematopoietic stem cell diversity and clonality in cardiovascular disease

Sleep is integral to health, and humans should be asleep for a third of their life. Poor or insufficient sleep raises
the risk of a number of pathologies including cardiovascular disease. However, the underlying biological
mechanisms that link sleep to cardiovascular health are unclear. Leukocytes of the myeloid lineage, sourced
from bone marrow (BM) hematopoiesis, play a central role in cardiovascular pathology, including
atherogenesis. Sleep fragmentation activates hematopoietic stem and progenitor cells (HSPCs) resulting in
monocytosis and enlarged murine atherosclerotic lesions. The proposed research aims to extend this
observation and explore how sleep shapes the epigenome of hematopoietic stem cells, their clonal expansion,
lineage commitment, and innate immune entrainment. Dr. Cameron McAlpine has developed innovative mouse
models of sleep fragmentation and disruption. Based on published and unpublished data, this proposal
hypothesizes that adequate sleep programs the epigenome of leukocytes, promoting an epigenetic profile that
fosters HSPC diversity, shapes HSPC lineage commitment, and influences innate immune entrainment. To
achieve these aims, innovative mechanical and genetic mouse models of sleep fragmentation will be used.
Using a fluorescent HSPC tagging system, the population dynamics of specific HSPC clones will be monitored
during sleep fragmentation. Further, HSPC clones that are dynamically regulated by sleep will have their
epigenome and transcriptome profiled. Additionally, using single-cell RNA-seq, the influence of sleep on the
entire BM HSPC compartment and its cell clusters will be analyzed. Using models of clonal hematopoiesis
targeting somatic mutations in epigenetic modifiers, the impact of sleep on clonal hematopoiesis driven
myeloproliferation and atherosclerosis will be determined. Finally, how sleep shapes innate immune
entrainment caused by diverse inflammatory stimuli will be questioned. Together, this proposed research will
provide a comprehensive view on the importance of sleep and its impact on hematopoiesis, the innate immune
system, and cardiovascular disease. Dr. Cameron McAlpine will conduct this work within the Center for
Systems Biology at the Massachusetts General Hospital and Harvard Medical School under the primary
mentorship of Dr. Filip Swirski and co-mentorship of Dr. David Scadden. Dr. McAlpine has assembled an
Advisory Committee comprising of Dr. Peter Libby, clinical cardiologist and expert in clonal hematopoiesis; Dr.
Kate Jeffery, an expert in leukocyte epigenetics; and Dr. Thomas Scammell, sleep clinician and expert on the
neurobiology of sleep. These mentors will allow him to develop a successful research strategy and career as
an independent biomedical investigator.

Public health relevance
This project aims to expand our understanding of sleep and its influence on cardiovascular disease and inflammation. Using innovative models of sleep, the proposed research will explore how sleep shapes the epigenome of hematopoietic stem cells; their clonal expansion, lineage commitment, and diversity; and the entrainment of the innate immune system. This research will unravel novel and fundamental biology linking sleep to inflammation and cardiovascular health.